Control of lethal prostate cancer with a bispecific av and a5b1 integrin antibody

ABSTRACT
The majority of the 300,000 annual deaths worldwide from prostate cancer are strongly attributed to bone
metastasis because the skeleton is the exclusive site of clinical disease in the majority of men with advanced
illness. There is a fundamental gap in our knowledge of the mechanisms that underpin the efficient and life-
threatening colonization of the bone microenvironment by prostate cancer cells. Our long-term goal is to
develop novel therapeutic strategies based on a molecular understanding of the pathophysiology of bone
metastases in order to significantly improve survival and quality of life outcomes in prostate cancer. Our
laboratory studies implicate two different but functionally related integrins expressed by prostate cancer cells in
their homing, survival and lethal spread within the bone microenvironment. The rationale of this study is that a
bispecific antibody that simultaneously targets these 2 integrins would optimally neutralize their function via its
cross-linking mechanism of action and deliver an efficacious therapeutic strategy. Accordingly, a first-in-class
bispecific antibody targeting these integrins demonstrated superior antitumor activity compared to
monospecific antibodies alone or in combination. A distinct molecular mechanism of action for the bispecific
antibody was defined. Following treatment with either or both monospecific integrin antibodies, adaptive
upregulation of the integrins was seen whereas by contrast, downregulation of integrins followed bispecific
antibody treatment via induction of internalization and lysosomal degradation of integrins. Our hypothesis is
that the bispecific integrin antibody will halt the life-threatening progression of prostate cancer in the bone
microenvironment. We plan to evaluate this hypothesis with three specific aims. First, we plan to assess the
efficacy of the bispecific antibody compared to monospecific antibodies in distinct animal models of bone
metastases that replicate key dimensions of the clinical disease: seeding of the bone marrow, interaction with
human bone-derived stromal cells, accelerated growth and secondary dissemination from bone, and finally,
generation of an osteoblastic phenotype. Secondly, we will further define the mechanism of action of the
bispecific integrin antibody by assessing its impact on epithelial-mesenchymal transition, anoikis and
clonogenic survival. Finally, we will determine the organ-specificity of the expression of the two integrins by
comparing the expression of these integrins in bone metastases from prostate cancer and other solid tumors to
metastases found in lymph nodes and visceral organs. Our innovative therapeutic strategy to disable the
molecular mechanisms of colonization of the bone microenvironment by prostate cancer is significant because
it has the potential to significantly prolong survival and improve quality of life of patients with prostate cancer.
Solid tumors that colonize bone such as breast cancer may leverage the same molecular pathways, expanding
the potential significance and impact of the bispecific antibody strategy in biomarker-supported clinical trials to
follow.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because therapeutic advances in treating bone metastases is likely to reduce the large number of deaths that disproportionately affects men of African and Caucasian descent. The proposed research is aligned with the NIH/NCI mission to develop fundamental knowledge in order reduce the burden of suffering and premature death from cancer.